Programmable evolution of optogenetic systems

Project Summary: The ability to use light to control biological processes has enabled the careful
dissection of biology and could be developed into future treatments for blindness, cancer, and many
other diseases. Systems that respond to red to near-infrared (NIR) light are particularly useful because
those wavelengths efficiently penetrate tissue, but these systems can be greatly improved by
engineering them to efficiently bind endogenous chromophores or to be more sensitive to light. By
using a new continuous evolution system, OrthoRep, we will evolve the Phytochrome B (PhyB)
optogenetic tool to use biliverdin (which is present in every cell) as a chromophore and evolve versions
that are activated by different wavelengths of NIR light. This will be accomplished by modifying the
Automated Continuous Evolution (ACE) that can automatically apply evolutionary pressure as the gene
of the optogenetic tool continuously mutates. Because PhyB will respond to light by activating a gene
essential for survival, it will be possible to evolve the activation wavelength, the amount of light that is
required to activate the gene, and the level of the activation once illuminated. Evolved PhyB mutants
that have useful properties will be validated/characterized biochemically and for controlling genes in
mammalian cells. The resulting optogenetic tools will enable new opportunities for in vivo optogenetics
and the modified ACE can be used to develop many other types of optogenetic tools, optical sensors,
and more.

Public health relevance
Project Narrative: Optogenetics has the ability to control biological processes with high spatiotemporal resolution and becoming an invaluable tool for biology and is a promising potential therapeutic tool. By building a programmable system for evolving the PhyB optogenetic system to utilize a new chromophore for light-controlled gene activation and to respond to different wavelengths of light, we will generate new optically controlled protein interactions that can be used for many optogenetic applications. In addition, by exploring the evolution of these new tools we will gain insights on how to generate better fluorescent proteins and inducible systems like optogenetics.